NAVIGATE-Kidney: Increasing diversity in the research workforce

PROJECT SUMMARY/ ABSTRACT
Compared to non-Latinx White individuals, Latinx individuals (gender-inclusive term; includes Hispanics,
Latino/a/e) have 2-times the risk of kidney failure and face a disproportionate burden of structural racism and
kidney health disparities. Latinx individuals are less likely to receive pre-dialysis nephrology care compared to
non-Latinx White individuals and as a result, are less likely to initiate person-centered kidney replacement
therapy (KRT), such as kidney transplantation or home dialysis. Latinx individuals are instead more likely than
non-Latinx White individuals to begin KRT with a central venous catheter, which has a higher risk of mortality
(1.4-1.5-fold) and fatal infection (1.5-2-fold) compared to an arteriovenous fistula or graft. Our community-
partnered research team developed and tested NAVIGATE-Kidney, a multi-level, language and culturally
concordant community health worker (CHW) intervention for Latinx individuals with kidney failure who receive
maintenance hemodialysis. Our funded parent grant (U01 DK137272-01) allows us to move beyond dialysis
center interventions by providing support to Latinx individuals with chronic kidney disease (CKD) stage 4/5.
Our team will conduct a patient-level randomized controlled trial of NAVIGATE-Kidney that will be implemented
across socioecological levels (individual, interpersonal, community, and societal) to mitigate structural racism.
We hypothesize that our NAVIGATE-Kidney intervention will reduce the composite primary endpoint, defined
as time to transition to KRT and central venous catheter use or death. In our plan for enhancing diverse
perspectives (PEDP), our team proposed mentorship of diverse nephrology physician scientists, trainees, and
CHWs as well as development of a kidney disease CHW training program. The PI, Dr. Lilia Cervantes, is a
nationally renowned leader in Latinx kidney disease health disparities research, who provides one to one
mentorship to nephrology scientists whose research and goals to eliminate structural racism align with her
own. This supplement will provide Dr. Cervantes with the protected time to provide mentorship to mentees on
how to conduct community-partnered research, grant writing, publications, technical skills development
including dissemination and implementation activities, and opportunities for networking. We also propose to
utilize supplement funds to support the team that will build the kidney disease CHW training program. This
training program will provide CHWs with the disease specific training for principal illness navigation certification
(required by the Centers for Medicare and Medicaid Services for reimbursement) and in doing so, will increase
diversity in kidney disease clinical trials, CHW intervention research, and the CHW research workforce. The
work proposed in this supplement aligns seamlessly with our parent grant PEDP, expands the research
proposed in our parent grant and the structural racism parent grant consortium, and will directly increase
diversity in the research workforce focused on kidney health disparities research.

Public health relevance
PROJECT NARRATIVE The Latinx community bears a disproportionate burden of chronic kidney disease, and they are less likely to start recommended kidney replacement therapy, such as kidney transplant or home dialysis, compared to non- Latinx White individuals. Our funded parent grant allows us to conduct a patient-level randomized controlled trial of NAVIGATE-Kidney, a multi-level, community health worker intervention for Latinx with kidney disease, that will reduce kidney health disparities. The proposed supplement builds on the parent grant plan for enhancing diverse perspectives (PEDP) by increasing the research workforce through direct one to one mentorship of physician scientists focused on kidney health disparities research and through the development of a kidney disease community health worker training program.